3D in vitro model of genetic and sporadic FTD: accelerating novel therapeutic development

Abstract
Up to 60,000 Americans suffer from frontotemporal dementia (FTD), a common form of dementia associated
with frontotemporal lobar degeneration (FTLD). The associated morbidity and cognitive and physical
impairments are accompanied by significant medical, societal, and financial burdens reaching billions of dollars
per year in the U.S. Effective diagnostics and treatments are lacking, and newer therapies have translated poorly
to humans, despite showing promise in existing in vitro and animal models. Accurate models of FTLD are needed
to advance the development of novel biomarkers, diagnostic and prognostic tools, and therapeutics. Brain
organoid systems are emerging to model complex human cellular interactions. However, cell types and numbers
are difficult to standardize due to reliance on cell lineage specification and the long maturation time within the
organoids. To solve this complex problem, Synapticure has developed a novel patient-derived 3D in vitro
platform for high-fidelity modeling and screening of pathological phenotypes and biomarkers associated with
neurodegenerative diseases. Synapticure’s cortical brain spheroids (CBS) are composed of key cells derived
from patient-induced pluripotent stem cells (iPSCs) and are custom assembled into 3D co-cultures, recapitulating
disease features not cumulatively seen in any existing in vitro or in vivo model. Synapticure has developed the
CBS model for ALS and now, through this Direct to Phase II SBIR, seeks to demonstrate the applicability of the
CBS platform to FTD patient-derived iPSCs. This will include developing model systems for different subtypes,
genetic and sporadic, of FTD. To evaluate the success of these models, the project team will assay markers of
TDP-43 proteinopathy, which contributes to disease in ~45% of FTD cases, as well as tauopathy, which
contributes to disease in 40% of FTD cases. This evaluation will include TDP-43 localization, the mis-splicing of
transcripts linked to TDP-43 proteinopathy, and tau splicing, expression level and localization. This project will
generate and validate CBS for genetic TDP43-FLTD, tau-FLTD, and sporadic FTD. Once validated, this platform
will enable the elucidation of novel druggable pathways, screening and validation of disease-specific biomarkers,
screening of potential therapies in patient-derived cell models, and better stratification of patient cohorts for
clinical trials.

Public health relevance
Narrative FTD is an Alzheimer’s disease-related dementia (ADRD) that is the second most common cause of dementia in patients younger than 65 and the third most common cause overall, and it is twice as costly as Alzheimer’s disease on a per-patient basis. A major challenge in the development and testing of new therapeutics is the lack of models that accurately reflect the underlying pathophysiology. Synapticure’s 3D in vitro platform will allow for more accurate modeling FTD, enabling the development of new biomarkers, prognostic tools, and ultimately novel therapeutics to better treat FTD patients.